Integrated mass spectrometry-based chemoproteomic and genomic technologies for studying dynamic kinase interactomes

PROGRAM ABSTRACT: Integrated mass spectrometry-based chemoproteomic and genomic technologies for studying dynamic kinase interactomes
Dynamic changes in protein-protein and protein-DNA interactions (PPIs and PDIs) control most cellular processes, including cell signaling and transcription; devastating diseases rewire PPI and PDI networks to drive disease progression, therapy resistance, and immune escape. Novel methods for mapping dynamic interaction networks are, therefore, urgently required to identify disease mechanisms and drug targets. Protein kinases are critical regulatory nodes in most cellular PPI and PDI networks, are often dysregulated in disease, and are highly druggable with synthetic, ATP-competitive inhibitors. Insights into how diseases utilize kinases to rewire PPI and PDI networks are extremely relevant for combating many diseases. Advances in quantitative mass spectrometry (MS) have revolutionized proteomics, yet facile methods for the systematic, sensitive, and high-throughput profiling of kinase PPIs, locus-specific PDIs, and their dynamics are lacking. We will develop transformative methods that combine cell-permeable affinity probes with chemical crosslinking and proximity labeling to globally encode kinase interactomes in situ, followed by integrated LC-MS and sequencing analyses.
Cellular plasticity drives physiological and pathological de- and transdifferentiation, and lineage switching, critically contributing to development, tissue repair, cancer metastasis, organ fibrosis, and therapy and immune escape in numerous diseases. To identify drug targets for combating these disease phenotypes, we need to understand the signaling and transcriptional network that underly cellular plasticity. Our studies of pathological kinome rewiring linked ~20% of human kinases to cellular plasticity, among them numerous understudied kinases. We found that 70% these kinases localize to the nucleus and interact with transcription factors and chromatin remodelers. We also found that cellular plasticity dynamically alters the post-translational modifications (PTMs) and PPIs of these kinases. How plasticity pathways coordinate dynamic changes in PTM, PPI and PDI networks to systematically alter chromatin states and transcription, however, remains largely unknown, leaving critical molecular mechanisms and drug targets unexplored. We will develop streamlined workflows for studying nuclear kinase dynamics, combining kinobead/LC-MS kinome profiling with global proteomics, epigenomics, and transcriptomics analyses, and our novel interactomic platforms, and apply these workflows to unravel how plasticity pathways spatiotemporally control kinases during cell state transitions.
To summarize, our program seeks to develop novel bioanalytical methods and workflows to systematically study dynamic kinase interactomes, and to illuminate the mechanisms of pathological cellular plasticity. Pursuing our goals, we created an ambitious, rigorous, and productive research program that fosters creativity and excellence, training the next generation of scientific leaders in proteomics, cell signaling, and chemical biology.

Public health relevance
PROGRAM NARRATIVE Protein-protein and protein-DNA interaction (PPI and PDI) networks control virtually all cellular processes, and they are commonly perturbed by devastating human diseases. To overcome key challenges in interaction network analysis, we will develop novel, transformative bioanalytical methods to quantify cellular PPI and PDI networks and their dynamic perturbation in disease, thereby enabling groundbreaking, broadly relevant discoveries of disease mechanisms and drug targets. We will apply our methods to unravel the interaction networks that control cellular plasticity, a biological process driving diverse pathological processes, including cancer metastasis, organ fibrosis, viral infection, drug resistance, and immune escape.